Optimizing Targeted Interventions for Primary Progressive Aphasia

PROJECT SUMMARY/ABSTRACT
Treatment options for primary progressive aphasia (PPA), a communication disorder associated with fronto-
temporal dementia (FTD) or Alzheimer’s Disease (AD) pathology, are extremely limited, and the psychosocial
and economic impacts of PPA are devastating. Knowledge of modifiable brain targets has not been harnessed
to catalyze meaningful treatment outcomes. Transcranial electrical stimulation (tES) allows systematic investi-
gations of the effects of brain target engagement and has strong clinical translational potential. While tES re-
search in PPA is encouraging, the over-reliance on tES protocols and recovery models used for stroke-induced
aphasia, rather than the development of approaches motivated by PPA neurobiology, has prevented vertical
progress in PPA treatment development. The fundamental underlying pathophysiology of progressive aphasia
warrants tailored approaches to intervention. There is a critical need for rigorous investigations that facilitate
identification of treatments capable of engaging modifiable brain targets for prophylaxis, restitution, and overall
improved disease management in PPA and other AD/ADRD. Failure to meet this need will unnecessarily delay
treatment advancements for clinical populations with no time to waste. The long-term goal of both the parent
grant and this supplement is to optimize neurorehabilitation for aphasia, whether due to stable or progressive
etiology, with clinically translatable brain-based treatments. The overall objective of this project is to strengthen
the impact of a current project on tES in stroke-induced aphasia (R01DC018282) by identifying and optimizing
adjunctive treatments that engage brain targets in people with PPA. This requires a neurotargeting foundation
grounded in PPA (rather than stroke) neurobiology and disease trajectory. Innovative pipelines developed in
the parent grant will be leveraged and combined with innovations in brain target selection specific to PPA and
its three consensus-based variants to develop essential tES tools and guidelines. Two specific aims will be
pursued: 1) Develop pipelines and guidelines for targeted modulation of intact cortex for each PPA variant; and
2) Use EEG to identify networks for targeting with tES for each PPA variant. Under the first aim, a shareable
pipeline for E-field modeling of multi-electrode transcranial direct current stimulation (tDCS) will be developed,
as will a normative dataset of modeled E-field distributions. Under the second aim, spectral EEG differences
between controls and people with PPA will be localized, laying the groundwork for future research with tran-
scranial alternating current stimulation (tACS). These contributions will be significant because the anticipated
development and sharing of resources will advance the validity and inferential precision of tES research for
PPA and other AD/ADRD, supporting development of future grant applications specific to neuromodulatory ad-
juvant treatments in these clinical populations who are in desperate need of innovations.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because optimizing treatment parameters based on individualized neurophysiology is broadly applicable to clinical populations who may benefit from improvements in function and psychosocial outcomes via adaptive brain reorganization. Thus, the proposed research is relevant to the NIDCD’s mission which seeks fundamental knowledge about the nature and behavior of living systems and to reduce the burden of illness and disability. It is also relevant to the NIA’s mission which seeks to better understand diseases associated with aging in order to extend the healthy, active years of life.